Defining the Potential of Gene Therapy to Correct Motor Disabilities of CTNNB1 Syndrome Using in Vivo Mouse and in Vitro Human Cell Models

CTNNB1 syndrome is an incapacitating developmental disorder characterized by intellectual disabilities, global
developmental delays (motor, language) and motor disabilities (truncal muscle hypotonia, distal muscle
hypertonia, spasticity, reduced muscle strength). The children have spastic gait or inability to walk, severely
impacting their quality of life. Their parents prioritize their being able to walk. No treatments are currently
available. The syndrome is caused by CTNNB1 (-catenin) haploinsufficiency due to de novo pathogenic
variants causing partial or complete deletions. Because it is a monogenetic disorder, we propose the first tests,
as proof-of-concept, that gene therapy can provide effective and safe therapeutic outcomes. We propose that
gene therapy will improve the reduced -catenin levels and significantly remedy the phenotypes. We will test our
hypothesis using two preclinical models of CTNNB1 heterozygosity, our in vivo mouse line and human iPSC
derived myotubes, a human cell type relevant to the motor disabilities of this syndrome. We will use newly
developed, next-generation muscle tropic AAVs to express CTNNB1/-catenin in the heterozygote models. New
studies report that one treatment with these AAVs provides safe, effective and long-lasting transgene expression
in mouse and non-human primate skeletal muscles in vivo and human myotubes in vitro, and significantly
remedies the phenotypes of two different neuromuscular myopathies in mice. Our CTNNB1 global heterozygote
mouse exhibits motor and cognitive impairments that resemble key features of CTNNB1 syndrome in children.
The motor impairments include reduced motor learning, coordination, and grip strength, relative to wildtype
littermates. We also find molecular changes in the het muscle consisting of altered levels of proteins that regulate
contractility, relaxation, and force in working muscle. Further, we find reduced levels of a muscle-derived
retrograde signaling factor required for normal motor neuron presynaptic terminal maturation. Our Aim 1 studies
will test whether direct transgene expression of CTNNB1 will improve -catenin levels in the CTNNB1 het mouse
skeletal muscle in vivo and human myotubes. Our dose-response tests will identify the lowest viral doses that
increase the reduced -catenin levels in the het models, test duration of the improved levels after the single
treatment, and absence of adverse effects. Our goal is to increase -cat levels in the mouse and human het
muscle cells, to resemble the normal baseline ranges of wildtype littermates and isogenic revertant control
myotubes, respectively. Aim 2 will test for statistically significant improvements in motor capabilities in vivo and in
molecular changes in the gene therapy treated mouse and human het models. We will use quantitative behavior
assays, immunoblotting and RT-qPCR. Our studies will provide the first insights into the efficacy and safety of
gene therapy for remedying pathophysiological changes caused by CTNNB1 haploinsufficiency. These critical
proof-of-concept studies in two preclinical models will inform the design of therapeutic strategies to provide life
altering benefits to children with CTNNB1 syndrome.

Public health relevance
Narrative: Treatment is lacking for CTNNB1 syndrome, an incapacitating childhood disorder that is characterized by motor and cognitive disabilities, and caused by CTNNB1 (-catenin) loss-of-function gene mutations resulting in haploinsufficiency. We propose the first proof-of-concept test of the therapeutic potential of viral gene therapy, using new, next-generation AAVs and two preclinical models, our CTNNB1 heterozygous mouse and human cell models. We will gain critical insights into the efficacy and safety of gene therapy for improving the reduced - catenin levels and significantly remedying phenotypes relevant to this severe disorder in children.